Molecular Mechanisms of PTEN and USP7 Regulation

Project Summary. This K99/R00 proposal concerns the structure, function, and regulation of key proteins
involved in cell signaling, PTEN and USP7. PTEN is a tumor suppressor lipid phosphatase that catalyzes the
removal of the 3'-phosphate from the membrane phospholipid phosphatidylinositol (3,4,5)-trisphosphate (PIP3)
to generate PIP2. Since PIP3 is a key regulator of cell growth and insulin signaling, it is imperative that PTEN
activity be tightly controlled. Loss of function PTEN mutations are frequently observed in cancer. PTEN is
post-translationally regulated by N-terminal ubiquitination and C-terminal phosphorylation but the detailed
structural and mechanistic impacts of these post-translational modifications (PTMs) are not well understood.
USP7 is a Cys hydrolase that is a deubiquitinase (DUB), catalyzing the cleavage of the ubiquitin/lysine
isopeptide bond. USP7's ubiquitinated protein substrates include PTEN and MDM2. Deubiquitination of PTEN
is reported to inhibit its translocation from the cytosol to the nucleus. Moreover, USP7 has been shown to
enhance the cellular stability of MDM2, and this is important because MDM2 is an E3 ubiquitin ligase for major
tumor suppressor protein p53. It is unclear what molecular features drive USP7's substrate selectively and
how it is regulated in the cell. USP7 is modified on both its N- and C-termini by phosphorylation and
acetylation but the regulatory roles of these PTMs are unclear. Here, we will address how PTEN and USP7
are regulated by PTMs using new and emerging semi-synthetic approaches. These semi-synthetic methods
can facilitate site-specific and stoichiometric installation of PTMs and their mimics into PTEN and USP7. Aim
1 seeks to define the molecular basis for PTEN regulation by C-terminal tail phosphorylation using structural
approaches. Conformational closure of PTEN is driven by phosphorylation of its C-terminal tail at positions
380, 382, 383, and 385 resulting in an inhibited enzyme, reduced plasma membrane binding, and increased
stability. This aim employs biomolecular NMR, crystallography, and mutagenesis to understand the structural
and mechanistic basis for conformational closure. Aim 2 will employ a series of biochemical and cellular
methods to define the function of Lys13 monoubiquitination, enhancing our understanding of how this PTM
may promote the shuttling of PTEN from the cytosol to the nucleus. Aim 3 will address what molecular
features drive USP7’s substrate selectivity and how USP7 PTMs (Ser18, Tyr1091, Thr1092, and Tyr1093
phosphorylation; Lys1096 acetylation and ubiquitination) regulate its function. Overall, these proposed studies
can greatly enhance our understanding of the function and regulation of PTEN and USP7 which can spotlight
possible targets for therapy. In addition, this proposal can also increase the PI's breadth of scientific skills and
experiences as he seeks to chart a course for an independent academic career.

Public health relevance
Narrative. The main objective of this proposal is to understand the structure, function, and regulation of two biologically related enzymes, PTEN and USP7. Protein semi-synthesis strategies will be used to install site- specific and stoichiometric post-translational modifications (PTMs) and non-hydrolyzable mimics in order to evaluate the substrate selectivity of USP7 and how PTMs influence enzyme structure and function. Results from these studies can pave the way to new therapeutics to treat a variety of human disorders including cancer.